Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
The Administrative Core will be an essential resource in the success or the Stanford O’Brien Center. The goals
of the Administrative Core will encompass external engagement, including integration with the O’Brien Center
Collaborative Network, interfacing with other programs in urological research, coordinating training activities
between research centers, and coordinating activities with NIDDK leadership. The Administrative Core also
directs the Research Center’s Educational Enrichment and Opportunity Pool Programs. The overarching goal
of the Administrative Core is to provide the operational support necessary to successfully achieve the goals we
have laid out for each project and program as a whole. The Administrative Core will be responsible for
managing, coordinating, and monitoring overall progress, and supervising the entire range of the program's
activities. Moreover, the Administrative Core will distribute results to scientific audiences and the general
public. We will maximize efficiency, cost-effectiveness, and productivity by centralizing resources used by each
of the projects and core. The Administrative Core has the following specific aims: (1) provide operational
oversight and integration of projects and cores, (2) promotion of effective collaboration, communication, and
interactions within and outside the Center, (3) provide an effective, centralized unit to manage finances and
resources, (4) broadly disseminate results and report Center activity, and (5) develop and execute the Center’s
Educational Enrichment and Opportunity Pool Programs. The organization of the Administrative Core will have
clear lines of authority and will leverage both an Investigator Committee and Internal and External Advisory
Committees to ensure effective use of resources, scientific guidance and evaluation, and clear decision-
making processes. Overall the Administrative Core will provide fully integrated administrative services for the
management, communications, coordination, and financial administration of the Stanford O’Brien Center.